A Hybrid Effectiveness-Implementation Trial of Treatments for Veterans with PTSD at Elevated Acute Risk for Suicide

Background: Posttraumatic stress disorder (PTSD) is a significant risk factor for suicide among Veterans.
Evidence-based psychotherapies (EBPs) for PTSD reduce suicide risk, but Veterans at elevated acute risk for
suicide, such as those who have engaged in self-directed violence (SDV), rarely receive these treatments. This
is largely due to the historical exclusion of high-risk individuals from PTSD treatment trials, which has resulted
in a lack of evidence-based guidance about indicated treatments for this population. Without such guidance,
clinicians are often reluctant to use EBPs for PTSD with suicidal individuals. A treatment that combines
Dialectical Behavior Therapy (DBT), a suicide-focused EBP, with the DBT Prolonged Exposure (DBT PE)
protocol for PTSD has been developed for this high-risk population and shows promise in reducing both SDV
and PTSD while being feasible, acceptable, and safe to deliver. However, a large-scale randomized controlled
trial (RCT) is needed. This study will compare the effectiveness of DBT + DBT PE to the current VHA gold
standard of care for this population, Prolonged Exposure therapy augmented with suicide risk management
(PE + SRM), while also examining the potential for implementation of both interventions in VHA.
Significance: There is a critical gap in knowledge about how to treat PTSD among individuals at high risk for
suicidal behavior. As a result, VA/DoD Clinical Practice Guidelines do not specify indicated treatment
strategies for this population. Experts have recommended two approaches to facilitate the safe and effective
use of EBPs for PTSD with individuals at elevated acute suicide risk, including combining these treatments
with suicide-focused EBPs or augmenting them with suicide risk management strategies. This project will help
to fill this critical gap by rigorously evaluating these two approaches among Veterans with SDV. The results will
provide important information to inform guidelines about indicated treatments for this high-risk population.
Innovativeness: This will be the first large-scale RCT to evaluate treatments for PTSD among Veterans who
have engaged in SDV, an HSR&D high priority group. The DBT + DBT PE intervention is the first treatment
designed to address both SDV and PTSD, and results will indicate if this novel treatment improves outcomes
compared to the current VHA gold standard of care. To facilitate more rapid implementation of these findings
into clinical practice, implementation barriers and facilitators for both treatments will also be evaluated.
Specific Aims: This study will randomize 200 Veterans with PTSD, recent and repeated SDV, current suicidal
ideation, and emotion dysregulation to DBT + DBT PE (intervention) or PE + SRM (control). Aim 1 will test the
hypothesis that DBT + DBT PE will be superior to PE + SRM in improving clinical outcomes and engagement
in trauma-focused treatment. Exploratory analyses will examine Veteran characteristics that may predict better
engagement and outcomes in DBT + DBT PE versus PE + SRM. Aim 2 will examine barriers and facilitators to
implementation of both treatments.
Methods: This is a multi-site hybrid type 1 effectiveness-implementation trial. Veterans will be treated in
outpatient settings at three VA sites and assessed at 5 points over 18 months. A mixed-methods approach will
be used to evaluate barriers and facilitators to implementation, including conducting interviews with 45 key
stakeholders (Veterans, providers, and leadership).
Primary Outcomes/Endpoints: Primary outcomes will be reductions in SDV episodes at 18-month follow-up
and reductions in PTSD severity at post-treatment.
Implementation/Next Steps: This project will provide much-needed information about how to safely and
effectively treat PTSD among Veterans at elevated acute risk for suicide. If one or both treatments are found
effective, Aim 2 will provide vital information about how to maximize future implementation success. Future
implementation activities would be coordinated with our national operational partners.

Public health relevance
Posttraumatic Stress Disorder (PTSD) is a significant driver of suicide risk among Veterans, but there is a critical knowledge gap about how to treat PTSD among people at elevated risk for suicide. Although evidence- based treatments for PTSD reduce suicide risk, Veterans at high risk for suicidal behavior rarely receive these potentially life-saving treatments. Prior research suggests that a treatment that combines Dialectical Behavior Therapy (DBT) with the DBT Prolonged Exposure protocol (DBT PE) for PTSD improves both PTSD and suicide-related outcomes. This study will evaluate whether DBT + DBT PE improves these outcomes more than Prolonged Exposure plus suicide risk management, the gold standard VA care for this population. The proposed study will also examine factors that make it easier and harder to implement these treatments in VA settings. The results will help to inform treatment guidelines for this high-priority Veteran population.